Urban Greenness and Cardiovascular Health

ABSTRACT
Although the results of many studies suggest that urban greenspaces have conducive effects of health, from
extant data it is difficult to isolate causal links or to identify the environmental and physiological processes that
contribute to the health-promoting effect of greenery. A better understanding and assessment of the health
effects of urban greenness is, therefore, needed to optimize its public health impact. To examine the effects of
greenness directly, we initiated the Green Heart Project, which is a community based clinical trial to test the
hypothesis that increasing neighborhood greenery diminishes the risk of cardiovascular disease (CVD) by
decreasing the levels of local air pollutants. In the first phase of the phase of the project, we acquired baseline
data on neighborhood characteristics and community health from 8 control (C) and 8 adjacent target (T) clusters
of neighborhoods in Louisville, KY. We acquired aerial hyperspectral and LiDAR scans of the area and conducted
stationary and mobile monitoring to develop high-resolution maps of local air pollution. We conducted in-person
exams to acquire baseline physical and psychosocial data. After acquiring baseline data, we planted mostly
evergreen mature trees, and upon completion of planting, we evaluated changes in pollution and reacquired
health data from in-person exams. We now plan to conduct follow-up studies to determine the long-term effects
of the greening intervention on the levels of air pollutants and the health of individuals living in the neighborhood.
For this, we assess CVD risk and psychosocial characteristics, and collect biospecimens from the cohort every
2 years for the next 4 years to quantify the impact of changes in greenery and greenness-related neighborhood
characteristics on differences in cardiovascular health. Using high-resolution hyperspectral and LiDAR imagery,
we will determine the effects of the greening intervention on neighborhood greenery and measure changes in
air pollution, temperature, and noise to evaluate whether the healthful effects of greenery are related to positive
changes in neighborhood characteristics. To ensure sustainability, we will identify barriers and facilitators,
including how urban greenness is perceived, used, and maintained, and estimate the ecosystem services
provided by the increase in greenery. Successful completion of the project will lead to a rigorous and direct
evaluation of the link between greenspaces and cardiovascular health. Findings of the project will help delineate
the contribution of environmental, psychological, social, and physical factors to the beneficial effects of greenery
and guide the development of new strategies for increasing sustainable healthfulness of urban neighborhoods.
By evaluating the impact of greenness on pollution and temperature, the project could provide new insights into
mitigating the effects of climate change. Lessons learned from implementation and sustainability and long-term
cost-benefit analyses of the greening intervention could inform the development of large-scale environmental
interventions to promote community health. Collectively, these results could inform new public health policies,
and facilitate evidence-based optimization of ongoing greening efforts worldwide.

Public health relevance
NARRATIVE This project is to assess the impact of urban greenspaces on community health. For this assessment, we acquired health data from individuals living in a low-to-middle income neighborhoods in Louisville, KY before and after planting a large number of mature trees and shrubs in the area. We have also acquired data on air pollution, before and after the planting. We now plan to study the long-term impact of this intervention on community health and the levels of air pollution in the neighborhoods.